Cancer Center Support Grant

PROJECT SUMMARY/ABSTRACT
This project is intended to support Dr. Nusayba Bagegni as an early career cancer clinical investigator and
clinical trialist with a focus on breast cancer and developmental therapeutics at Washington University School
of Medicine, Siteman Cancer Center to support NCI-funded clinical research activities and training. The
Applicant's interest is in designing and conducting early-phase breast cancer clinical trials and identifying
predictive biomarkers of response and resistance to improve breast cancer outcomes for those with aggressive
breast cancer subtypes and advanced breast cancer. The Applicant is committed to establishing an academic
career in clinical research, serving both as site and overall PI for a number of NCI-funded therapeutic and
interventional clinical trials. The Applicant is vigorously involved in developing and implementing investigator-
initiated trials to address unmet need for aggressive breast cancer subtypes requiring novel therapeutic
approaches, as well as trials of therapy efficacy monitoring, and inclusion of underrepresented minorities, the
latter of which is extremely lacking in breast cancer clinical trials.

Public health relevance
PROJECT NARRATIVE Breast cancer is the most common cancer worldwide and is the leading cause of cancer death in women. The goal of this project is to support Dr. Nusayba Bagegni's goal to design and lead NCI-funded breast cancer therapeutic trials and facilitate clinical research education and training in clinical drug development. Her mission is to contribute to lessening the burden of breast cancer, with a focus on aggressive breast cancer subtypes, by designing and leading therapeutic clinical trials.